Neurophysiological Social Reward Processing, Birth Trauma, and Depression Symptoms in the Peripartum Period

PROJECT SUMMARY/ABSTRACT
Peripartum depression (i.e., depression during pregnancy and following childbirth; PPD) is prevalent and
debilitating for women. PPD is associated with significant negative outcomes, including functional impairment
and suicidality risk in mothers as well as cognitive, developmental, emotional, and social impacts on infants.
Another common factor impacting women during the peripartum period is birth trauma. Nearly half of women
giving birth endorse birth trauma, including labor complications, emergency interventions that violate
expectations, or needs for intensive medical treatment. Depression during pregnancy is a known risk factor for
birth trauma. Further, birth trauma is associated with a range of adverse outcomes for mothers and offspring
similar to the effects of PPD. Many women endorsing birth trauma do not develop PPD, raising questions
about vulnerabilities for depression that may contribute to PPD in interaction with birth trauma. Vulnerability-
stress models of depression posit depression is the result of interactions between underlying vulnerabilities
and stress. Growing evidence supports the use of neuroscientific methods to identify depression vulnerabilities
across development, such as reduced neural reward responsiveness. Further, stress moderates effect of
reward processing on subsequent depression. Reward processing may interact with birth trauma on PPD
symptoms. As part of a larger project, this project measures neural social reward responsiveness using a novel
and ecologically valid paradigm, birth trauma objectively coded based on contextual factors, and depressive
symptoms assessed in 120 mothers. Depression symptoms and diagnoses are collected across pregnancy
and postpartum. During an assessment at 8 weeks postpartum, participants complete a novel social inventive
delay task while electroencephalogram is recorded in response to reward (i.e., green arrow leading to a photo
of participant’s infant) and neutral feedback (i.e., red arrow leading to a photo of rocks). Event-related potential
(e.g., the reward positivity, a time-domain measure of reward responsiveness) and time-frequency data (i.e.,
delta activity, a frequency-domain marker of sensitivity to rewards) are used to measure neurophysiological
response to social reward. Further, participants complete the Birth Experience Interview to capture dimensions
of birth trauma (i.e., overall severity, violations of expectations, and loss of control). The project examines the
effects of low social reward responsiveness (Aim 1) and birth trauma (Aim 2) on PPD symptoms, accounting
for depressive symptoms during pregnancy. Further, the project tests birth trauma as a moderator of
associations between social reward responsiveness and postpartum depressive symptoms, accounting for
depressive symptoms during pregnancy (Aim 3). This project brings together experts in respective fields and
allow for advanced training on the role of stress and trauma in PPD, advanced EEG methods, and advanced
quantitative methods. The project and training provide opportunities to develop necessary skills for an
independent career as a researcher identifying processes and environmental factors driving PPD risk.

Public health relevance
PROJECT NARRATIVE Both blunted neural social reward responsiveness and birth trauma may play a role in greater risk for peripartum depression (PPD). To identify underlying processes that may interact with birth trauma in driving PPD risk, and as part of a larger longitudinal study, the current proposal will examine the effects of low social reward responsiveness and specific aspects of birth trauma on postpartum depressive symptoms. Results of this proposal will inform future strategies to reduce the adverse outcomes associated with PPD for mothers and their offspring.